Engaging residents to sustain healthier homes

The proposed project, “Engaging Residents to Sustain Healthier Homes,” builds on 20 years of community-
academic partnership to address health disparities in Rochester, NY through reducing low income families’
exposures to environmental hazards. Our research evaluates a low-cost intervention to reduce home-based
environmental exposures through home health surveys and urine samples. The home is a major contributor to
environmental exposures, particularly for pregnant women and young children. These exposures have significant
implications for lifelong health disparities. New York State has been conducting a Healthy Neighborhoods
Program (HNP) with community outreach workers for the past 30 years that involves education, low cost
supplies, and referral to resources. This sustainable, low-cost intervention program has been shown to reduce
certain home hazards and improve asthma outcomes; however, the impact on residents’ exposures has yet to
be quantified through environmental (house dust) or biological (urine) monitoring, which may elucidate
connections to other health outcomes including adverse neurodevelopmental and reproductive health effects.
We aim to determine the impact of the HNP on resident exposure and use these results to inform future studies
on the potential of a low-cost community-based intervention to improve maternal and child health outcomes. The
proposed project leverages an existing HUD-funded intervention study (ROC HOME) involving analysis of dust
in the homes of low-income homeowners in Rochester, NY. Half of the ROC HOME participants are receiving
the HNP intervention; the other half are controls. We propose to add urine measurements to participants recruited
from both arms of the ongoing ROC HOME study to explore urinary biomarkers of home environmental
exposures among an understudied population for whom the HNP holds great potential for promoting
environmental health. We will recruit 60 reproductive-aged women from the 100 ROC HOME study participants,
collecting urine samples at two time points. Aim 1 will compare urine concentrations of pesticides, phthalates,
and flame retardants post HNP intervention between treatment and control groups and estimate the association
between exposure concentrations measured in household dust and urinary metabolite concentrations. Aim 2 will
assess participant engagement in the home interventions before and after receiving their personal exposure
results through a community partnership. The data collected will provide critical information to shape the design
of future, scalable intervention studies that can measure the exposure reductions and health benefits of home-
based hazard reduction interventions. Our long-term goal is to inform implementation and dissemination of low-
cost, sustainable, community-based healthy home programs to reduce maternal and children’s exposure to
environmental toxicants and promote lifelong health.

Public health relevance
Project Narrative The proposed research evaluates a low-cost intervention to reduce home-based environmental exposures by leveraging an ongoing HUD-funded study of dust levels of flame retardants, phthalates, and pesticides in low- income homes. We will measure metabolites of these same chemicals in women’s urine, conduct a survey to document resident engagement with the intervention, and interview residents to evaluate report-back of individual study results in partnership with a community group. This research will inform design of future community-engaged research to test, disseminate, and implement low-cost, sustainable, comprehensive healthy housing interventions to improve environmental health.